Secondary Analyses of Clinical Trial Data to Understand Factors Associated with Alcohol Use Among Alaska Native Populations

Project Summary/Abstract
This project proposal reflects a collaborative and coordinated training and research plan that will facilitate
the applicant’s transition towards becoming an independent alcohol researcher within Alaska Native (AN)
communities. Namely, four training goals are proposed: 1) Develop expertise in alcohol treatment and clinical
trials research within the AN population; 2) Obtain proficiency in traumatic stress research and the impact of
trauma on alcohol use among AN people; 3) Acquire methodological and advanced quantitative skills for
designing and analyzing clinical trials; and 4) Further develop scientific writing skills, strengthen publication
record, and grow professionally as an AN alcohol researcher and future leader in the field. These skills will be
applied to carrying out the proposed project of examining two randomized control trial datasets related to
alcohol use disorder (AUD), problematic drinking, smoking, trauma, culture, and quality of life (QOL). Clinical
trials data will be from (1) the Naltrexone Study39, a clinical trial of naltrexone and sertraline for the treatment of
AUD among an AN and non-Native sample; and (2) the HEALTHH Study42, a clinical trial for people who
smoke tobacco that includes two interventions to promote heart health (a) tobacco cessation and physical
activity and (b) medication adherence and a heart healthy AN diet. Research examining AN representation in
clinical trials for major mental disorders between 1986 and 2005 found that not one of the 10,000 participants
were from American Indian (AI) or AN heritage5. Moreover, an exhaustive literature search in 2014 of AI/AN
mental health treatment intervention resulted in only two clinical trials. This is more than troublesome given the
fact that AN people experience disproportionately high rates of AUD, problematic drinking, alcohol-related
injury and death, smoking, health disparities, high rates of PTSD and traumatic stress, and systemic racism
and oppression2,5,12,16,25,48. These factors impact the very fabric of AN culture, wellbeing, and alcohol treatment
access, utilization, and outcomes8,13,23. Thus, this project will explore the extent to which trauma, smoking, and
culture impacts drinking and QOL outcomes. Aim 1 is to examine predictors of alcohol use and moderators of
naltrexone treatment effects among AN people using data from the Naltrexone Study and Aim 2 is to examine
the impact of drinking on the efficacy of two culturally tailored interventions targeting modifiable risks for
cardiovascular health and the effects of these intervention on drinking among AN people using data from The
HEALTHH Study. Resultant data from these aims have the potential to identify the nature and impacts of
factors associated with alcohol use, treatment, and outcomes among AN people, which is of great public health
importance. Additionally, the results have implications for developing trauma-informed, culturally derived,
multilevel alcohol treatment interventions for AN people.

Public health relevance
Project Narrative Alaska Native (AN) people have alarmingly high rates of alcohol use disorder, problematic drinking, alcohol relate injury and death, and yet are underrepresented in clinical trials research, treatment planning, and the development of alcohol interventions specifically for them. The proposed research will contribute to fundamental knowledge about culturally salient, multilevel interventions for alcohol treatment among AN people that are destigmatizing (e.g., focused on medication adherence, healthy eating, exercise), decolonizing (e.g., culture is protective), and indigenizing (i.e., inclusive of AN participants and an AN PI). Moreover, the present project posits that trauma, modifiable physical health indicators, and culture have a key and interactive role in increasing quality of life and in adapting treatment and improving alcohol outcomes for AN people.